Application of Economics & Social psychology to improve Opioid Prescribing Safety (AESOPS) Trial

3URJUDP 'LUHFWRU 3ULQFLSDO ,QYHVWLJDWRU /DVW )LUVW 0LGGOH Doctor, Jason N. 8VH RQO\ LI DGGLWLRQDO VSDFH LV QHHGHG WR OLVW DGGLWLRQDO SURMHFW SHUIRUPDQFH VLWHV Additional

Public health relevance
Narrative This project aims to understand social and behavioral determinants of COVID-19 antibody testing in underserved populations. In partnership with the largest federally qualified health center in the United States, we will collect survey data and conduct a randomized experiment on 2,160 individuals (540 families) to evaluate the effectiveness of messaging and incentives to facilitate repeat testing for SARS-CoV-2 antibodies. We also evaluate how social and behavioral determinants affect efforts to encourage repeat serology testing.